Research Education Component

REVISED ABSTRACT: RESEARCH AND EDUCATION CORE
The overarching goal of the Research and Education Core (REC) of the Michigan Center on Contextual
Factors in Alzheimer’s Disease (MCCFAD) is to increase and educate the professional research workforce
addressing the brain and cognitive health of older adults. REC is central to MCCFAD because it directly
educates, mentors, and supports junior and mid-career investigators. Increasing the professional research
workforce, particularly those who study the brain and cognitive health of older adults is critical to advancing
knowledge about and improving the care of older adults in the U.S. REC synergy with the Leadership and
Administrative, Analytic, and Community Liaison and Recruitment Cores will be instrumental in achieving these
aims, as will collaborations with rich resources available at the University of Michigan (UM), including NIA
Centers, Inter-Consortium for Political and Social Research, the Health and Retirement Study (HRS), and
partner institutions (Michigan State University, Wayne State University, Oakland University, UM- Dearborn).
REC specific aims are to: (1) Support pilot studies for MCCFAD Research Scientists (RS) in ADRD
epidemiology, health economics, and tailored ADRD care; (2) Provide sustainable mentoring activity for
MCCFAD RS to achieve independent investigator status; (3) Offer professional development and education in
ADRD disparities; and (4): Evaluate REC activities. Expert mentorship in health disparities research will
primarily be provided to RS through an individualized, integrative and often trans-institutional mentoring team,
a monthly seminar series, professional development sessions, and a yearly Summer Data Immersion (SDI)
program to catalyze new and enduring research collaborations. Moreover, RS mentoring activities will continue
beyond the year they are funded. We have designed a unique and exceptional educational experience that will
increase the workforce’s interest in and knowledge about contextual factors related to ADRD. A team of expert
faculty will guide these activities, which exemplify the overarching REC core value of team science. The impact
of the REC is expected to be broad because we have designed activities to target and benefit not only funded
RS (e.g., integrative mentoring team; monthly seminar series), but also national researchers (e.g., SDI) and
the larger scientific community as a whole (e.g., peer-reviewed publications and presentations at professional
meetings generated through RS pilot projects and SDI activities, workshops on the responsible conduct of
research and working with NIH-designated populations with health disparities.